CEREBRAL METABOLISM IN KETOSIS AND EPILEPSY

This project seeks to understand the basis of brain ketone utilization under states of increased ketone availability such as during prolonged fasting and under the influence of a ketogenic diet. Preliminary work has concluded that the physiologically specific D beta hydroxybutyrate (BHB), gives a greater detectable increase than the unspecific DL anomeric mix in plasma BHB levels when infused, since biochemical assays for BHB are stereospecific for the D isomer. We have demonstrated that after 72 hours fasting, an infusion of sodium D-betahydroxybutyrate can increase plasma BHB levels from about 4mM to 6mM. Acetoacetate (AcAc) levels are about 1mM as expected. Work has been completed on obtaining a pyrogen free supply of sodium acetoacetate. Future infusions will include a physiological mix (4:1) of BHB and AcAc. Initial magnetic resonance studies of brain ketosis at 4.0T indicate that BHB and lactate levels can be quantified in brain tissue when plasma ketone levels are about 4-7mM.